Tree-based population genetics methods for genetic epidemiology

PROJECT SUMMARY
With the advent of high-throughput sequencing, pathogen genetic data have become an increasingly important
source of information in the study and surveillance of infectious diseases. However, current computational
methods for genetic epidemiology do not adequately capture the complexities inherent in the genetic
consequences of realistic disease dynamics. This limitation hinders our ability to fully exploit this rich data source.
The core challenge involves incorporating epidemic, ecological, and evolutionary factors, along with their
interactions, into the computational framework. My lab’s central aim for the next 5 years is to address this
challenge by developing novel statistical and computational methods, drawing on our expertise in population
genetics, applied mathematics, and computation. First, we will develop efficient coalescent-based phylodynamic
methods to jointly infer genealogies and model parameters based on pathogen genetic data while incorporating
realistic biological and epidemiological processes associated with latent and polyclonal infections. We will devise
new algorithms and inference frameworks capable of handling the inherent complexities in these scenarios
based on the seedbank coalescent and metapopulation coalescent theories, respectively. Beyond the
applications in genetic epidemiology, the newly developed methods will also provide a fundamental
understanding of populations undergoing dormancy and metapopulation dynamics. Second, we will develop
scalable inference frameworks for phylodynamics using pathogen genealogies (representing evolutionary and
epidemiological relationships among samples) as an input data structure. Our approach will include integrating
tree encoding with deep learning techniques and ensemble learning strategies to handle large datasets and
model complexities, enabling a more robust and comprehensive framework for genetic epidemiology. Third, we
will create a comprehensive epi-eco-evolutionary simulator that will be integral to generating synthetic data that
accurately reflect real-world scenarios, thereby facilitating the development and testing of new hypotheses,
algorithms, and models. Importantly, this tool will directly address the currently understudied epi-eco-evolutionary
coupling, offering insights into how the genetic evolution and transmission dynamics of pathogens are intertwined.
Finally, we will apply the conceptual and methodological advances from our research to the existing whole-
genome sequencing dataset of Mycobacterium tuberculosis, the causative agent of tuberculosis. In summary,
my research program will provide a deeper mechanistic understanding of how epidemiological, ecological, and
evolutionary processes and their interplay shape the genetic diversity and epidemic trajectories of pathogens.
This information will lay the foundation for improving the management and control of infectious diseases, such
as tuberculosis, which disproportionately affects socioeconomically underprivileged populations.

Public health relevance
PROJECT NARRATIVE Genetic data from pathogens have become an increasingly crucial source of information for understanding, forecasting, and managing the spread of an epidemic. However, current computational methods in genetic epidemiology do not fully capture the complexities of the genetic consequences of realistic disease dynamics, limiting our ability to harness the full potential of this rich data source. My research program will bridge this gap by developing advanced computational methods based on population genetics principles, providing fundamental insights into how epidemiological, ecological, and evolutionary processes shape pathogen genetic diversity, and thereby improving infectious disease surveillance, prediction, and management.